STUDIES OF HEREDITY AND ENVIRONMENT IN SCHIZOPHRENIA

This project has been composed of the following studies: (1) An intensive multi-disciplinary study of a family with MZ quadruplets (daughters) concordant as to schizophrenia but discordant as to severity and outcome; (2) Studies of Danish Adoptees and their biological and adoptive families: (3) A study of children (of schizophrenic and control parents) reared in town or kibbutz in Israel. We maintain contact with the quadruplets, and have recently conducted neuropsychological and cytogenetic studies on them, in conjunction with the staff of the Karolinska Institute and the VA Hospital of Pittsburgh, PA. The Danish adoptees are of continuing interest to us and we are preparing additional reports on factors involved in their psychiatric outcome. The Israeli children have been the subject of intensive research efforts and we have published a series of behavioral and psychophysiological studies on them.